Core 2: Survey and Data Collection

PROJECT SUMMARY - SURVEY AND DATA COLLECTION CORE (SDCC)
The primary objective of the Survey and Data Collection Core (SDCC) is to provide all Program Project
investigators and staff with a centralized resource for measurement and data collection. To achieve this goal,
our SDCC team will collaborate with the investigators and health system partners and the other cores.
The specific aims for the SDCC are to:
1. Collaborate with the project investigators in the selection, development and design of individual project and
overall measures and data collection procedures;
2. Identify and implement common measures across all projects to examine the influence of the Social
Determinants of Health as specified by the Multilevel Model of Population Health;
3. Train intervention and clinic staff across the three projects and the health care systems, as needed, in the
study instruments and data collections procedures;
4. Utilize the electronic health record systems (EHRs) for participant identification, intervention delivery, and
data collection for all three projects; and
5. Monitor data tracking systems for the individual projects and the overall program and work with staff to
minimize missing data and missed patient assessments.
The Core will be led by Drs. Michelle Naughton (The Ohio State University) and Thomas Guterbock (University
of Virginia). The coordination and data collection from electronic health records will be under the direction of Dr.
Adam Baus at the West Virginia University, in partnership with the staff at the participating health systems. The
team of investigators and staff is highly qualified to complete the specific aims of the SDCC and support the
overall program project and three integrated projects. The Core will work in close cooperation with the
Intervention and Consortium Core (ICC) to develop data collection approaches and procedures that are
integrated into community structures and culture throughout Kentucky, Ohio, West Virginia and Virginia. The
SDCC will also work closely with the Biostatistics and Evaluation Core (BEC) to ensure the collection of quality
data for the planned analyses. The Administrative Core (AC) will then utilize the project results produced by
the SDCC and BEC to facilitate the dissemination of the study results and effective interventions to reduce
disparities in cervical cancer incidence and treatment.

Public health relevance
PROJECT NARRATIVE – CORE 2 (SDCC) The SDCC is integral to the proposed Program Project by providing outcomes measurement and data collection services across all three projects. This core will assist in advancing our scientific knowledge of HPV prevention strategies through interventions designed to promote HPV vaccination rates, increase HPV self-testing, and decrease smoking rates in Appalachia. These outcomes directly coincide with the NCI stated goals of improving women's health and cancer prevention strategies. This project also has public health relevance by targeting the Appalachian region of the U.S., which has high rates of tobacco use and cervical cancer, in order to decrease cancer incidence, as well as morbidity and mortality, in line with the Health People 2020 objectives.